Role of p62 in metabolic reprograming of the tumor stroma in prostate cancer

SUMMARY The process by which not only cancer cells but also other components of the tumor microenvironment respond to nutritionally challenging conditions is not well known. The proposed study will provide a detailed understanding of the mechanisms whereby the PCa epithelium educates the stroma by downregulating p62, and how p62-deficient stroma reprograms its metabolism to generate a microenvironment more resistant to nutrient stress. This application is based on two sets of preliminary data: 1) p62-deficient stromal cells reprogram their metabolism to mediate stromal resistance to glutamine (Gln) deprivation, and promote the growth of PCa epithelial cells even under Gln-limiting conditions; 2) stromal p62 is downregulated by lactate secreted by the PCa epithelium by JunB-mediated repression of the p62-promoter. Based on these data, we hypothesize that p62 downregulation in the stroma by PCa cells constitutes a tumor strategy for the PCa epithelium to obtain the metabolic support necessary to proliferate under the Gln-deprived tumor microenvironment. We will address this fundamental problem in cancer biology in the following Aims: (1) Define how p62 deficiency reprograms stromal metabolism in Gln-deprived conditions. We hypothesize that ATF4 upregulation is central to the mechanisms whereby the loss of p62 in stromal cells reprograms glucose metabolism to compensate for the lack of Gln. To test this hypothesis, we will: (1A) Mechanisms of ATF4 regulation by the p62-PKCζ/λ complex; (1B) Define how p62 deficiency reprograms serine/glycine metabolism in response to Gln deprivation through PKCζ/λ-ATF4; (1C) Define how p62 deficiency promotes Asn synthesis in response to Gln deprivation through PKCζ/λ-ATF4; (1D) Define how the p62-PKCζ/λ-ATF4 signaling cascade regulates pyruvate metabolism; (1E) Determine the functional relevance of p62-dependent stromal metabolic reprograming in PCa in vivo. (2) Define how p62 is downregulated by PCa in the tumor stroma: To unravel the mechanisms that regulate p62 repression in this context, we will: (2A) Identify the lactate- responsive AP-1 site in the p62 promoter; (2B) Characterize the JunB-containing AP-1 complex regulated by lactate; (2C) Define the role of NRF2 in JunB-mediated p62 repression; (2D) Define the biological relevance of the identified transcription factors and signaling pathways that induce p62-downregulation. This innovative proposal will fill a key gap in the cancer metabolism field by defining the relationship between metabolic rewiring and signaling in the tumor stroma and its impact on PCa progression. The impact of these findings will instruct new therapeutic strategies aimed at manipulating the metabolism of the stroma.

Public health relevance
PROJECT NARRATIVE How cancer cells respond to nutritionally challenging environments, and the role that the stroma plays in that adaptation is poorly understood. The proposed study will provide a detailed understanding of the mechanisms whereby the stromal compartment generates a metabolic microenvironment more resistant to nutrient stress in prostate cancer. These studies are of great significance and impact, as they will define how the manipulation of the metabolism in the stroma impacts prostate cancer progression, which will serve to identify new therapeutic targets.